IGF::OT::IGF PURPOSE: To exercise Option Period, extending the period of performance and obligating additional fund.

The purpose of this SBIR Phase II contract is to develop an inexpensive and easy to use instrument that will be capable of measuring low ppm levels (at least <5 ppm) of a range of metals typically used in the pharmaceutical industry. The instrument would be co-located with the reaction and purification equipment where metal removal is performed, and preferably, amenable to continuous monitoring of metal impurities associated with continuous processing operations.